STRUCTURAL INVESTIGATION OF GLYCOSYLTRANSFERASES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. We are interested in understanding the biological function and mechanism of several bacterial and human glycosyltransferases. We have developed methods to express, purify, and kinetically characterize glycosyltransferases that are important for bacterial pathogenesis and human disease. We have also implemented screens to look for inhibitors of some of these glycosyltranferases. These inhibitors can serve as biological probes of these enzymes and could help determine whether these proteins are viable therapeutic targets. An important aspect of this endeavor is to obtain structural information about these targets. A structure for these glycosyltranferases would be invaluable for the purposes of both mechanistic understanding and inhibitor development. We are therefore interested in obtaining structures of these enzymes in the apo form, with substrate bound, and with inhibitors bound.